Computational alchemy for molecular design and optimization

PROJECT SUMMARY/ABSTRACT
Pharmaceutical drug discovery is time-consuming and expensive, with each new drug brought to market now
costing well over $1 billion on average. This cost is driven by the difﬁculty of drug discovery, and in part by the
amount of trial and error involved in the process of ﬁnding initial “hits” which modulate the function of a biomolecule,
and then reﬁning these into “leads” which have adequate afﬁnity for the biomolecular target and other desirable
properties. Here, we develop and improve computational methods to guide this process, allowing the potential
efﬁcacy of prospective leads to be tested computationally prior to their creation — dramatically reducing the
amount of trial and error involved in the process and guiding the molecular design process.
Here, we build on previous work in the group and the ﬁeld on alchemical free energy calculations based on
molecular simulations — the most promising present computational technique for guiding drug discovery. However,
such techniques work well only for a limited subset of cases, require considerable expertise to employ, and even
their limitations are not yet well understood. Here, we focus on expanding the range of systems which can be
treated with these techniques, making the calculations more robust and rapid, improving accuracy, and identifying
and isolating remaining deﬁciencies for repair.
Alchemical free energy calculations hold particular promise both because of their accuracy and physical real-
ism. Here, we focus on technology and applications of these calculations, focusing on (1) improved efﬁciency
and accuracy of binding free energy calculations; (2) automation and large-scale benchmarking of free energy
calculations to guide work to ensure robustness and accuracy; and (3) applications to utilizing simulations and
free energy calculations to guide lead discovery and optimization of SUMO E-1 inhibitors as potential anti-cancer
drugs. Broadly, Aims 1-2 focus on iteratively improving and testing computational tools, whereas Aim 3 focuses
on a speciﬁc application with experimental collaborators.
This work promises more accurate and more rapid free energy calculations, with broader scope so that they can
reliably be applied to molecular design problems in drug discovery and elsewhere. Our long-term work aims to
produce a workﬂow where a chemist developing new molecules to bind a particular target could input hundreds
of potential compounds to synthesize next into a computer before leaving work one day, and return to work the
following morning to ﬁnd these compounds automatically prioritized based on predicted target afﬁnity, selectivity,
solubility and other properties, allowing years worth of synthesis and assays to be bypassed. Here, we develop,
test and apply technologies to help make this workﬂow possible, building on our extensive previous success in
physical modeling for binding prediction. This also leverages and extends technologies built in our prior R01.

Public health relevance
PROJECT NARRATIVE Pharmaceutical drug discovery produces dramatic public health beneﬁts through new and improved treatments for common diseases and disorders, but it is an expensive, time-consuming process involving much trial and error, and failure is common. This work focuses on dramatically improving computer tools to predict interactions between small molecules and molecular machines, and applies these tools to an anti-cancer drug discovery project. The proposed project produces and improves tools which will guide development of new drugs, and will directly use these to assist in anti-cancer drug discovery; both the tools and the proposed application provide potential public health rewards.